Haplotype-resolved genome assemblies and chromosomal rearrangements in arboviral vector Aedes albopictus

PROJECT SUMMARY
The Asian tiger mosquito Aedes albopictus is native to Southeast Asia but in a few decades this species
expanded its range to all continents except Antarctica. Aedes albopictus is capable of transmitting multiple
arboviruses including dengue—the leading arboviral disease of 21st century—Chikungunya, and Zika—an
emerging health threats for the world. Because of its remarkable ability to develop a photoperiodic diapause in
the temperate climate, Ae. albopictus has the potential to spread these dangerous diseases further north. This
project will develop haplotype-resolved chromosome-scale genome assemblies for multiple strains of Ae.
albopictus and will test if adaptations to the temperate climate are associated with chromosomal
rearrangements in this mosquito. Toward this end, we propose the following specific aims: 1) develop a
haplotype-resolved chromosome-scale genome assemblies for four strains of Ae. albopictus including
the Foshan strain; 2) improve the physical genome map for the Foshan strain of Ae. albopictus; and 3)
identify chromosomal rearrangements in different populations of Ae. albopictus world-wide. Our long-
term goal is to understand the genetic basis of the incredible phenotypic plasticity of Ae. albopictus that helps
this mosquito to rapidly spread around the globe. We envision that the availability of the high-quality reference
genome assemblies for multiple strains of Ae. albopictus will stimulate further genetic studies aimed at
preventing mosquito-borne disease transmission.

Public health relevance
PROJECT NARRATIVE The most successful invasive mosquito species Aedes albopictus is a vector of dangerous arboviruses, such as dengue, Chikungunya, and Zika. Unlike other mosquitoes, Ae. albopictus can easily adapt to different natural environments and climates because of its remarkable ability to develop a photoperiodic diapause under cold environmental conditions. To better understand the wide phenotypic plasticity of this mosquito and to facilitate the development of new technologies for mosquito control, this project will create haplotype-resolved chromosome-scale genome assemblies for multiple strains of Ae. albopictus and identify chromosomal rearrangements associated with adaptations of this mosquito to different environments.